Mechanistic and Functional Evaluation of a Model of Cerebral Small Vessel Disease

PROJECT SUMMARY
Vascular contributions to cognitive impairment and dementia (VCID) describes any level of cognitive alteration
attributable to cerebrovascular pathologies. After Alzheimer disease, VCID is the second leading cause of
dementia and accounts for ~15-30% of all dementia cases. Cerebral small vessel disease (cSVD) accounts for
up to 20% of all strokes and is the most common pathology underlying VCID. Importantly, the pathogenesis of
cSVD is poorly understood which represents a major barrier for developing therapies. COL4A1 and COL4A2
mutations cause multisystem disorder for which cSVD disease is the major consequence. Cerebrovascular
disease in individuals with COL4A1 or COL4A2 mutations have hallmarks of cSVD – subcortical microbleeds,
enlarged perivascular spaces, and lacunar infarcts and Col4a1+/Mut mice faithfully model patient phenotypes.
Moreover, Col4a1+/Mut mice have age-related cerebrovascular dysfunction including loss of myogenic tone and
impaired hyperemic responses that are thought to be critical to VCID progression. Importantly, strong genetic
evidence indicates that COL4A1 and COL4A2 contribute to general cerebrovascular health and idiopathic cSVD
suggesting that understand pathogenic mechanisms contributing this form of monogenic cSVD may also provide
important insight into idiopathic cSVD and VCID.
We discovered that TGFβ signaling is elevated in Col4a1+/Mut mice, genetically decreasing TGFβ signaling
ameliorates cSVD severity in mice, and that acutely inhibiting TGFβ signaling restores myogenic tone to ex vivo
cerebral arteries from Col4a1 mutant mice. Here, we seek to understand the molecular mechanisms by which
collagen IV a1a1a2(IV) regulates TGFβ signaling. We will also use mouse models to perform intravital imaging
of the cerebral vasculature and cerebral hemodynamics, evaluate behavioral assays of cognitive impairment,
and test hypothesis that dysregulation of matrix metalloproteinases contribute to pathogenesis. The successful
completion of this project could provide significantly greater understanding of idiopathic cSVD and establish
clinically relevant in vivo outcomes for testing future disease modifying therapies for an important monogenetic
form of cSVD.

Public health relevance
PROJECT NARRATIVE Cerebral small vessel disease is a major cause of vascular contributions to cognitive impairment and dementia (VCID); however, the causes are poorly understood representing a major barrier in developing effective therapies. We propose to close this knowledge gap by determining cellular and molecular mechanisms for an important monogenic form of cerebral small vessel disease and establishing relevant in vivo outcome measures for a preclinical model.